Supplement: Enhancing Community Contributions to Bioconductor With Build System Containerization and a GPU for Testing

PROJECT SUMMARY/ABSTRACT
"Bioconductor: An Open-Source, Open-Development Computing Resource for Genomics" is the
parent grant of this application for supplemental funds. Bioconductor is an open source, open
development ecosystem of software and data for the analysis and comprehension of genome-
scale experiments. The system is primarily rooted in the R language but has extensive
interoperability capabilities and incorporates tools developed in numerous other
languages. Bioconductor resources are requested at scientific and industrial sites throughout
the world, with an outflow from Bioonductor's cloud distribution systems of approximately 1TB of
software and data per day. The system provides infrastructure for genome representation and
representation of variants, genomic sequences and gene models for numerous model
organisms, analytical software for many array and sequencing platforms, and annotation and
experiment archives, all checked for consistency and portability on a daily basis. This request
for supplemental funds addresses engineering requirements of the build and distribution
system, which has had its present structure for over ten years, and adds support for graphical
processing units in the build and test system. Our plan includes work on containerization and
upscaling of the build and check system, and enhancement of the methods of recording
resource use and adverse events in ecosystem build processes. In essence, the proposed
work will allow the Bioconductor project to more fully embrace an "Infrastructure as Code"
discipline to simplify redeployment and rescaling in response to throughput requirements, and to
improve automatic discovery and reporting of system problems. Because the requirements of
the genomic data science community are continually diversifying in terms of complexity and
volume of data being generated, and the number of hardware platforms in use is likewise
growing, the work proposed cannot be accomplished under the initial funding plan.

Public health relevance
PROJECT NARRATIVE Bioconductor is an open source, open development ecosystem of software and data for the analysis and comprehension of genome-scale experiments. Hundreds of methodologists have contributed and continue to maintain open software tools for the quality control and analysis of sequencing experiments in the Bioconductor environment, which provides highly reliable data structures and software testing and distribution processes serving thousands of sites in academia and industry worldwide. This supplement request addresses needs for refactoring the systems for continuous integration and distribution of Bioconductor resources, and introduces GPU hardware in the testing system as the number of packages using GPU-oriented components is growing.